Brain-gut circadian rhythm interactions in alcohol-induced gut leakiness

DESCRIPTION (provided by applicant): The goal of this proposal is to test the novel hypothesis that disruption of synchrony between brain-gut circadian rhythms either directly by alcohol, or by environmental or genetic manipulations, is the vulnerability factor responsible for the differential susceptibility for EtOH-induced intestinal hyperpermeability that explains why only subset of alcoholics develop gut leakiness to endotoxins and steatohepatitis [ASH]. Our hypothesis is supported by: (1) Gut leakiness is a major contributor to endotoxemia and gut-derived endotoxin is required for ASH; (2) while EtOH universally disrupts intestinal epithelial monolayer permeability, gut leakiness occurs in only a subset of alcoholics, suggesting other factors might be involved-variability in gut leakiness; (3) The core circadian clock molecular machinery is within all organs including the central circadian clock in the hypothalamic suprachiasmatic nucleus (SCN), and intestinal epithelial cells. The SCN regulates and coordinates the expression and timing of multiple peripheral circadian molecular rhythms, possibly including brain-gut interactions of the so called brain-gut axis, (BGA); (4) The BGA can regulate intestinal permeability, and pathological stimuli like physical and psychological stress can cause gut leakiness; (5) The circadian modulation of the brain gut communication could affect intestinal permeability since circadian genes regulate apical junctional complex (AJC) protein genes that are directly involved in regulation of intestinal permeability. Our recent in vivo mice data showed that disruption of circadian rhythms makes the intestine susceptible to injury. Also, our pilot data in Caco-2 intestinal monolayers show that alcohol stimulates expression of the clock genes Clock and Per2 and that siRNA knockdown of these genes prevents alcohol-induced monolayer hyperpermeability. We also show that Clock and Per2 proteins are increased in the intestines of alcohol fed rats with leaky gut. To test our hypothesis, we will take two different approaches. First (in Aim 1), we will use both environmental [constant phase shifts in the entraining LD cycle] & genetic [Clock mutant and Per1/Per2 KO mice] approaches to disrupt the overall circadian organization of mice to determine if such disruption leads to increased vulnerability for EtOH-induced gut leakage to endotoxins in alcohol-fed mice (8 wk chronic model). We predict that these circadian manipulations will elucidate the roles of circadian brain-gut synchrony and intestinal cell clock genes in regulating intestinal apical tight junctional proteins and gut permeability in response to chronic alcohol feeding. Second (in Aim 2), we will assess how EtOH-induced changes in central and peripheral clock function and gene expression impacts permeability to endotoxin (3 day acute and 8 wk chronic models). We predict that alcohol-mediated central and/or intestinal circadian desynchrony will result in increased injury to apical junctional complex (AJC) leading to gut leakiness. Demonstrating that circadian- mediated disrupted brain-gut communication is one critical contributing susceptibility factor for alcohol- induced endotoxemia would provide new targets for preventive and therapeutic interventions in ASH.

Public health relevance
PUBLIC HEALTH RELEVANCE: NARRATIVE Most people are aware that our bodies operate according to biological rhythms. These biological rhythms appear to regulate many aspects of our health but little is known about the cellular mechanisms involved. This study will test how alcohol affects the biological rhythms of the intestine as well as the brain and liver to see if this is one way alcohol can cause diseases such as alcoholic liver disease. Identifying how alcohol affects these biological rhythms in these organs may help us design new treatments for alcoholic liver disease and other alcohol related diseases. NARRATIVE Most people are aware that our bodies operate according to biological rhythms. These biological rhythms appear to regulate many aspects of our health but little is known about the cellular mechanisms involved. This study will test how alcohol affects the biological rhythms of the intestine as well as the brain and liver to see if this is one way alcohol can cause diseases such as alcoholic liver disease. Identifying how alcohol affects these biological rhythms in these organs may help us design new treatments for alcoholic liver disease and other alcohol related diseases. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS. The overall goal of our alcohol (EtOH) research program is to identify the mechanisms that determine why only a subset of alcoholics are susceptible to gut leakiness (intestinal hyperpermeability) of the luminal bacterial products like endotoxins. Achieving this goal is important in advancing our knowledge of the mechanisms that lead to EtOH-induced organ damage because 1) We and others have substantial evidence to indicate that endotoxin is involved in the initiation of sustained inflammatory cascades that are required for EtOH -induced tissue injury, including alcoholic steatohepatitis (ASH), 2) gut leakiness is a major contributor to endotoxemia, and 3) alcoholism causes tissue injury such as ASH in only about 20-30% of alcoholics, and the reasons behind this differential susceptibility remain unknown. In addition, while EtOH universally disrupts intestinal epithelial monolayer permeability, gut leakiness occurs in only a subset of humans, and also only in a subset of EtOH fed rats, suggesting other factors outside of the direct effects of EtOH on intestinal epithelial cells might be involved for these differential biological and clinical outcomes- (variability in gut leakiness). The present proposal focuses on the role of disrupted circadian rhythms as an important factor responsible for the differential susceptibility for EtOH-induced gut leakiness because of several key findings linking circadian rhythms, alcohol, and the gut, including: (1) The core circadian clock molecular machinery is within essentially all the tissues and organs of the body including the central circadian clock in the hypothalamic suprachiasmatic nucleus (SCN), and intestinal epithelial cells; (2) The SCN regulates and coordinates the expression and timing of multiple peripheral circadian molecular rhythms, possibly including brain-gut interactions of the so called "brain-gut axis," (BGA); (3) The BGA can regulate intestinal permeability, and disruption of this communication by pathological stimuli like physical and psychological stress can cause gut leakiness in both humans and rodents. The circadian modulation of the brain gut communication could mediate normal & pathological states of intestinal permeability since circadian genes regulate apical junctional complex (AJC) protein genes that are directly involved in regulation of intestinal permeability; (4) Alcohol can disrupt the central SCN circadian rhythm in rodents and affect expression of clock genes in the brain; (5) Chronic alcohol consumption can directly phase shift rhythms regulated by the SCN in a subset of alcoholics; (6) Desynchrony between central and peripheral clocks appears to underlie a variety of metabolic disorders; (7) We have recently demonstrated that chronic disruption of the central circadian clock in mice can lead to an increased vulnerability of the intestine to chemically (DSS)-induced colitis: a model where intestinal hyperpermeability is the primary pathogenic mechanism. In addition, we have exciting new preliminary in vitro and in vivo data to suggest a central role for alcohol-disrupted circadian genes in alcohol-induced gut leakiness, including: 1) Alcohol treatment of intestinal Caco-2 cells that disrupts monolayer permeability also stimulates expression of the canonical circadian clock genes, Per2 and Clock; 2) The knock down of Clock or Per2 gene expression by siRNA prevents this alcohol-induced intestinal epithelial cell monolayer hyperpermeability; and 3) Both Per2 and Clock proteins are increased in the intestinal mucosa of alcohol fed rats with gut leakiness. To test our hypothesis that the circadian clock is involved in EtOH-induced gut leakiness, we will take two different approaches. We will: (1) Disrupt circadian rhythmicity at the cellular level in the gut and between the brain-gut axis using environmental & genetic perturbations; (2) assess the impact of EtOH-induced circadian desynchrony at the brain-gut axis or gut tissue level on development of gut leakiness. Aim 1: To test the hypothesis that chronic disruption of circadian rhythm synchrony increases susceptibility to EtOH-induced gut leakiness to endotoxins. We will use both environmental & genetic approaches to disrupt the overall circadian organization of mice to determine if such disruption leads to increased vulnerability for EtOH-induced gut leakage to endotoxins. In one series of studies, wild-type mice will be exposed to constant phase shifts in the entraining LD cycle, while a second series will involve mice that have been altered genetically. These genetic studies will utilize the Clock mutant and Per1/Per2 KO mice where the mutations lead to a disruption or abolishment of circadian rhythmicity at behavioral & physiological levels under constant environmental conditions (i.e. constant darkness). We predict that these circadian manipulations will elucidate the roles of circadian brain-gut synchrony and intestinal cell clock genes in regulating intestinal apical tight junctional proteins and gut permeability in response to chronic alcohol feeding. Aim 2: To test the hypothesis that EtOH-induced circadian desynchrony itself may lead to EtOH- induced gut leakiness to endotoxins. Since the effects of alcohol for inducing circadian desynchrony could be due to either direct effects of EtOH on intestinal epithelial circadian genes regulating intestinal permeability, or disrupted communication between central and intestinal circadian genes by alcohol's effects on the SCN central clock, we will assess how EtOH-induced changes in central and peripheral clock function and gene expression impacts permeability to endotoxin (3 day acute and 8 wk chronic models). We predict that alcohol- mediated central and/or intestinal circadian desynchrony will result in increased injury to the apical junctional complex (AJC) leading to gut leakiness. Demonstrating that circadian-mediated disrupted communication between the brain and gut is one critical contributing "susceptibility" factor for alcohol-induced endotoxemia would provide a novel approach and a paradigm shift for risk stratification of organ dysfunction in alcoholics. Central and/or peripheral organ circadian genes & circadian desynchrony would thus represent new targets for preventive and therapeutic interventions for alcohol-induced intestinal tissue injury and & possibly other organ dysfunction in alcoholics.